Fibrogenic Role of ROCK delta1 and Mechanism in Cardiac Remodeling

DESCRIPTION (provided by applicant): We identified Rho kinase ROCK1 as caspase-3 target in human failing hearts. The cleavage resulted in a constitutively active Rho kinase, ROCKΔ1. We also demonstrated that genetic deletion of ROCK1 inhibited stress-induced cardiac fibrosis. However, the function of ROCKΔ1 and molecular signaling linking ROCK1 to cardiac fibrosis remain obscure. The goal of the study is to determine the fibrogenic role of ROCKΔ1 and investigate molecular mechanism of ROCKΔ1-mediated cardiac fibrosis. To address these questions, we generated transgenic mice expressing ROCKΔ1 in heart to mimic human heart disease. Overt cardiac fibrosis was observed with marked upregulation of TGFβ1 in the transgenic mice. Since activation of Rho kinase increased SRF activity, we assessed the transgenic heart and found manifest increase in SRF activity. Our preliminary results suggested SRF as a potential regulator of TGFβ1. We also found robust increases in NF-κB expression and activity in the mice. Therefore, the central hypothesis is that constitutive activation of ROCK1 in cardiomyocytes is sufficient to result in cardiac fibrosis by upregulating TGFβ signaling and other pro-fibrotic cytokines through activation of SRF and NF-κB, respectively. Three aims will be completed. Aim I is to determine the pro-fibrotic effect of ROCKΔ1 in intact heart. The transgenic mice will be studied under basal and stress challenging conditions. The fibrogenic phenotype will be determined in two mouse lines with high and low expression level of ROCKΔ1. A rescue experiment by Rho kinase inhibitor will be conducted. Aim II is to elucidate the molecular mechanisms of ROCKΔ1-mediated cardiac fibrosis. The signaling pathway linked between Rho kinase and fibrotic response has been proposed with a considerable amount of preliminary data. The proposed mechanism includes the upregulation of TGFβ1 and NF-κB-mediated cytokines. The hypothesis will be tested in vitro in cardiomyocytes and in vivo in the transgenic mice. To investigate SRF-directed TGFβ1 regulation, the identified cis elements in TGFβ1 promoter/enhancer region will be verified by extensive experiments including 1) luciferase, EMSA and CHIP assay; 2) through transgenic mice expressing lacZ driven by either the wild or mutant cis elements; 3) by analyzing expression of TGFβ1 in SRF null mouse heart, where the decrease in TGFβ1 level is expected. Aim III is to determine if the loss of endogenous ROCK1 inhibitor, Rnd3, recapitulates ROCKΔ1-mediated fibrotic cardiomyopathy. The fibrotic phenotype, Rho kinase activity, TGFβ and NF-κB signaling will be assessed under normal and stress challenging conditions. The outcome of the proposal will be to establish links between the activation of Rho kinase, TGFβ1 and NF-κB signaling in fibrotic cardiac remodeling. The innovation of the proposal includes 1) demonstration of fibrogenic role of ROCKΔ1; 2) elucidation of the ROCK1->SRF->TGFβ1->fibrosis and the ROCK1->NF-κB->cytokines->fibrosis signaling pathways; 3) revelation the role of Rnd3 in cardiac remodeling; and 4) implication of manipulating Rho kinase activity and caspase cleavage as candidate therapeutic targets.

Public health relevance
Project narrative: The study is to determine the fibrogenic role of the constitutively active ROCK 1 in intact heart, and to elucidate the molecular mechanism involved in Rho kinase-mediated cardiac fibrosis. The genetic-manipulated murine mice are applied.